Center Administration

SUMMARY
The MRI Resource for Physiologic, Metabolic and Anatomic Biomarkers has an Administrative Core that
coordinates all NCBIB activities, i.e. the development and dissemination of qualitative and quantitative MRI
biomarker technologies based on fast multi-modal multi-contrast imaging and spectroscopy approaches, as
well as the training in their use.
Daily operation of all aspects of the NCBIB is the responsibility of the MPIs of this core, Drs. Peter van Zijl and
Hanzhang Lu, both experts in magnetic resonance technology development with longstanding experience in
managing NIH grants and multicenter and multi-disciplinary collaborations. They head the Resource Executive
Committee in which they will manage this task through close interaction with the other PIs heading the four
technical research and development (TRD) projects. The full committee meets bimonthly or whenever
necessary. The TRD PIs are all in close proximity and meet/interact closely at least on a weekly basis. The
general goals of the Resource are formulated by this Executive Committee with guidance from the internal and
external advisory committees. The main goal is to create an environment that allows biomarker technology
development through the push-pull interaction between the physicists and engineers of the TRDs and the
application scientists and clinicians heading the collaborative projects. In addition, the Resource supports
many service projects as test beds of the methodology in important areas of application. The committee also
assures that technology is further disseminated through presentations, training courses, and software and data
transfer to interested sites (See Training and Dissemination Section).
The Resource has a set of carefully designed operating procedures to establish the above-mentioned
collaborative and service projects and for the management of the facilities in terms of safety and equitable
access to the scanners and facilities. Plans for long-term maintenance of the facility assure that the NCBIB can
function successfully.
The progress of the Resource will be overseen by an External Advisory Committee (EAC) consisting of experts
in biomarker development and in the technical fields of our TRDs. This committee will meet annually to advise
on scientific progress and on the progress of the center in terms of its goals of collaboration, service, training
and dissemination. A yearly report will be submitted to NIBIB as part of the annual progress report. In addition
to the EAC, we have several local committees that provide oversight, including a protocol review committee
that evaluates all research projects in terms of human safety and research quality.
The Resource has very strong institutional support, as outlined in letters by the president of Kennedy Krieger
Institute and the Chairs of Radiology and Biomedical Engineering at Johns Hopkins University.